Validation of the Diagnostic and Predictive Tool, D2HGlo, for the Quantification of the Oncometabolite D-2-Hydroxyglutarate (D-2-HG) in Glioma

Summary
This proposal describes a collaborative effort between Northern Michigan University (NMU), Johns Hopkins
University (JHU), and the F.M. Kirby Research Center for Functional Brain Imaging at the Kennedy Kreiger
Institute for the analytical and clinical validation of the novel, genetically encoded FRET-based probe, D2HGlo.
The intended use for this diagnostic and predictive tool includes preoperative and post-operative characterization
of mutant IDH (isocitrate dehydrogenase) glioma through detection of the surrogate biomarker
and oncometabolite, D-2-hydroxyglutarate (D-2-HG), which is the product of the mutant IDH enzyme. D2HGlo
has the potential to modify current mutant IDH glioma treatment modalities as this diagnostic tool is anticipated
to predict patient response to therapeutic strategies months earlier than standard MRI analysis of disease
progression. The 2021 World Health Organization (WHO) classification of central nervous system (CNS) tumors
identifies mutant IDH gliomas as a biologically and clinically distinct group, adding emphasis on the development
of an assay to characterize this category of tumors. The absence of an assay utilizing a liquid biomarker has
been a significant hurdle for diagnostic and prognostic care of mutant IDH glioma patients and this shortcoming
can be remedied as D2HGlo specifically detects D-2-HG from non-invasive clinical specimens. Here, we propose
to characterize the first liquid biomarker assay allowing for the specific, inexpensive, and non-invasive detection
of D-2-HG in urine, serum, and plasma, as well as cerebrospinal fluid. Of significance to this proposal is the
success of the mutant IDH inhibitor, vorasidenib, a mutant IDH 1/2 inhibitor. A phase III clinical trial for this
therapeutic agent recently (September, 2023) demonstrated clinical utility by maintaining disease stability and
providing a delay in the need for additional therapeutic interventions. The success of vorasidenib caused the trial
to be halted permitting patients from the placebo group to be placed on the therapy as well. With few side effects
identified, the scientific and healthcare communities expect FDA approval of vorasidenib and its use in treating
patients with mutant IDH glioma. With the significant advent of this mutant IDH therapy, D2HGlo is perfectly
positioned to address the clinical laboratory need for a liquid biomarker assay to determine if and when a patient
is failing therapy. By monitoring D-2-HG production in patients with mutant IDH glioma utilizing D2HGlo, cycles
of chemotherapy are more likely to be attenuated, resulting in both physical and fiscal relief to the patient. In
addition, D2HGlo is highly amenable for implementation in locations where treatment resources are limited,
thereby increasing patient access to needed healthcare. This proposal offers validation of a fluid-based test for
D-2-HG and has the potential to become a cost-effective integrated biomarker to predict tumor treatment
response and tumor recurrence, thereby guiding clinical decision-making beyond that achievable using current
imaging tools. In summary, validation of D2HGlo has the potential to drastically transform current mutant IDH
glioma treatment regimens while significantly reducing the financial and physical burdens of the disease.

Public health relevance
Project Narrative This proposal focuses on the analytical and clinical validation of D2HGlo for the characterization of mutant IDH glioma. This diagnostic tool is expected to predict therapeutic response and tumor progression earlier than current techniques utilizing an inexpensive and non-invasive test. Validation of the D2HGlo has the potential to modify current treatment modalities, thereby decreasing the personal and financial burden of the disease.